Artificial Intelligence for Thoracic Aortic Disease Screening and Gene Discovery

PROJECT SUMMARY
Thoracic aortic dissections are a leading cause of premature death, especially in those with heritable thoracic
aortic disease (HTAD) who carry pathogenic variants (PVs) in genes predisposing to dissection. Early HTAD
diagnosis, surveillance of aneurysms, and elective surgical repair can effectively prevent aortic dissections.
Unfortunately, many individuals go undiagnosed and consequently fail to receive early medical interventions and
preventive surgery, resulting in death in up to 50% of dissection cases, including in childhood. Therefore,
improved screening methods for HTAD are essential, particularly in children and cases where syndromic features
are missed. While genetic testing has become integral to diagnosing HTAD, these genes explain less than 30%
of cases. Thus, there is a pressing need for improved screening methods and a deeper understanding of the
genetic causes of HTAD – areas where Artificial Intelligence (AI) can make significant contributions. In this
proposal, Dr. Murdock proposes developing a state-of-the-art AI-based facial recognition tool specifically
designed for HTAD using facial images from the Montalcino Aortic Consortium (MAC), an international patient
registry of over 1,500 individuals with genetically mediated aortic disease. Preliminary results on vascular Ehlers-
Danlos syndrome (vEDS) illustrate that this cutting-edge approach identifies vEDS accurately and distinguishes
it from hypermobile EDS (hEDS), a larger patient group that does not have deadly vascular complications. This
screening method could rapidly identify patients with potential PVs in HTAD genes, facilitating early detection
from the pediatrician's office to emergency room settings. Additionally, Dr. Murdock proposes using machine
learning and quantitative evolutionary information to identify new HTAD genes from large, diverse groups,
including local HTAD cohorts, the UK Biobank, All of Us, and the Penn Medicine BioBank. Exciting preliminary
findings using this approach on the UK Biobank dataset suggest the potential role of a novel myosin heavy chain
gene, MYH9, in aortic dissections. The proposed work will take place at The University of Texas Health Science
Center at Houston (UTHealth) in the Division of Medical Genetics within the Department of Internal Medicine.
Dr. Murdock will conduct his research under the mentorship of Dr. Dianna Milewicz, a world-renowned expert in
aortic disease, and an impressive advisory team of experts in cardiovascular genetics (Dr. Siddharth Prakash),
artificial intelligence (Dr. Xiaoqian Jiang), computational genomic analysis (Dr. Olivier Lichtarge), and
biostatistics (Dr. Cici Bauer). Dr. Murdock aims to become an NIH-funded independent investigator, leveraging
his clinical, molecular, and computational background to improve the outcomes of individuals at risk for thoracic
aortic disease. By receiving additional mentorship and training through the K08 award, he is confident he will
acquire the necessary skills to transition to independence successfully.

Public health relevance
PROJECT NARRATIVE Thoracic aortic dissections, a leading cause of premature death particularly in those with heritable thoracic aortic disease (HTAD), are entirely preventable if at-risk individuals are identified early and undergo surgical repair. Artificial intelligence (AI), including machine learning and deep learning approaches, represents an ideal method for identifying these individuals and gaining insights into the largely undefined genetic basis of aortic disease. In this proposal, I aim to (1) develop an AI-based facial feature screening tool by leveraging images from the Montalcino Aortic Consortium patient registry, and (2) integrate machine learning techniques and evolutionary principles to identify novel genetic drivers of HTAD using genomic-scale data from diverse cohorts.